New Approaches to Combat CNS Inflammation: Targeting a Metabolic Enzyme in Demyelinating Disease

Multiple sclerosis (MS) is a debilitating demyelinating disease of the central nervous system (CNS) that
affects approximately 2.5 million people worldwide. US military personnel are at special risk to develop MS:
the incidence rate in the US military population (12.9 per 100,000 person-years) is 1.7x higher than the civilian
population, and 3x higher than the global population. Experimental autoimmune encephalomyelitis (EAE) is a
widely studied animal model that shares many features of human MS. Tissue injury in EAE and MS is caused
by inflammatory leukocytes that enter the CNS and destroy myelin. CNS-infiltrating, myelin-reactive CD4+ T
cells play key roles in the pathology of MS. Although a number of MS treatments are available, due to the
heterogeneity of the MS disease process, individual patient responses, and medication toxicities, there is a
substantial unmet clinical need for improved therapeutics.
Leukocyte differentiation and function is profoundly affected by the engagement of metabolic pathways for
lipid or retinoid processing. Diacylglycerol O-acyltransferase-1 (DGAT1) is a metabolic enzyme that can
catalyze the synthesis of triglycerides (via DGAT activity), and retinyl esters (via acyl CoA:retinol
acyltransferase (ARAT) activity). Little is known regarding the role of DGAT1 in leukocyte biology. We
published that DGAT1 is selectively upregulated in activated mouse CD4+ T cells both in vitro and in vivo
during EAE. DGAT1 is selectively expressed in brain lesions and CD4+ blood T cells obtained from MS
patients. Both conventional DGAT1 KO mice and mice we generated with CD4+ T cell-selective deficiency in
DGAT1 (tamoxifen-treated CD4CreERT2+/-DGAT1fl/fl) were protected against EAE and histological CNS
inflammation and demyelination. Furthermore, DGAT1 pharmaco-inhibition can be used therapeutically to
improve clinical EAE. Our preliminary studies indicate that genetic deficiency in DGAT1 leads to increased
regulatory T cell (Treg) numbers and frequency; that polyfunctional Treg proliferation is enhanced in vitro in
DGAT1 KO cells; and that suppressor activity is increased in DGAT1 KO Treg from normal and EAE mice. We
therefore hypothesize that DGAT1 serves as a novel immune checkpoint for Treg that can be targeted to
enhance Treg proliferation and activity to combat MS.
In Aim 1, we propose to investigate if DGAT1 small molecule antagonists enhance human and mouse
regulatory T cell proliferation/suppressor activity and extend remission in the relapsing-remitting PLP-SJL EAE
model. Notably, DGAT1 inhibitors are already being tested in clinical trials for treatment of obesity-associated
diseases. Thus, the studies outlined in Aim 1 have the potential to prompt swift repurposing of existing, safe,
well-characterized DGAT1 inhibitors and offer real translational opportunities to improve the lives of Veterans
and other patients with MS. In Aim 2, we will define the role of DGAT1 in regulatory T cell trafficking to the
CNS during demyelinating disease. Our preliminary data indicates that chemokine receptor CCR6 is
upregulated in DGAT1-deficient Tregs, which we hypothesize contributes to their increased frequency in the
CNS during EAE. We will use CCR6 KO mice to ask if CCR6-dependent Treg trafficking to the CNS is
required for the protective effects of DGAT1 inhibitor in EAE. We also propose to use transcriptomic profiling
to compare gene expression signatures of CNS Treg from DGAT1 KO vs. WT EAE mice to identify additional
differentially-expressed trafficking receptors and regulatory pathways impacted by DGAT1. In Aim 3, we will
use conditional DGAT1-deficient mice to define the role of DGAT1 in CD4+ T cells, regulatory T cells, and
neutrophils in clinical EAE and CNS histological inflammation and demyelination. The bulk of our preliminary
data clearly points to a major pathogenic role for DGAT1 in CD4+ T cells and Tregs in EAE. In new
preliminary data, we also uncovered high expression of DGAT1 in neutrophils along with alterations in
neutrophil abundance during EAE. Neutrophils are known to contribute to EAE pathogenesis.

Public health relevance
Multiple sclerosis (MS) afflicts nearly 50,000 veterans, and the military population is at special risk to develop MS compared to civilians. Despite recent medical advances, there remains a substantial unmet need for additional effective MS treatments. Injury to the brain and spinal cord in MS is caused by autoimmune inflammatory T cells that enter the central nervous system and attack the myelin sheath. T cell activity is regulated by lipid and vitamin A metabolism. Our project focuses on the role of a metabolic enzyme we recently discovered to be expressed in T cells. Inhibiting this enzyme protects animals from developing MS- like symptoms. A detailed understanding of the molecular and cellular mechanisms of immune suppression by targeting this metabolic enzyme may lead to new approaches to treat or prevent MS and possibly other autoimmune or inflammatory disorders. If successful, this project has the potential to substantially reduce the impact of MS on veterans, their families, and the American public.